Materials and Macromolecules Tailored for Micro and Nanoscale Organic Synthesis

Abstract
High-throughput experimentation has revolutionized organic synthesis and pharmaceutical lead identification by
enabling the design, execution, and analysis of previously unimaginable quantities of experiments. This
paradigm shift over the past two decades has transformed the landscape of chemical research by accelerating
nearly every aspect of synthesis and analysis. These advances have been realized, in part, through engineering
developments such as automated liquid handlers. However, these engineering innovations have also led to
certain chemical limitations. Many reagents and catalysts, despite being highly useful in conventional synthesis,
are excluded from modern HT approaches because they are not compatible with automated liquid handlers used
in standard HT workflows. The omission of these important compounds has resulted in significant limitations in
current HT approaches. This proposal outlines efforts to address some of these gaps. Specifically, it outlines
efforts to adapt heterogeneous materials and macromolecules to modern HTE approaches to better utilize their
unique properties in organic synthesis. In the first goal, we aim to develop colloidal suspensions of commonly
insoluble inorganic reagents, allowing them to be processed as homogenous liquid solutions. These reagents
will undergo benchmarking in important cross-coupling reactions, including cross-electrophile couplings and in
engineering challenges. In the second goal, we focus on the development of material and macromolecular
analogs of commonly used, yet cytotoxic reagents, facilitating direct to biology synthesis and assays. Our
research emphasizes macromolecular analogs of organic super bases and metal scavengers that are particularly
relevant to high-throughput catalysis. Lastly, in the third goal, we plan to synthesize and evaluate easily
accessible site-isolated catalysts for transformations historically constrained by bimolecular decomposition. This
includes electrophilic carbon-hydrogen bond functionalization and mild fluoro-dediazotization reactions. The
completion of these studies will yield innovative tools for modern synthesis and pharmaceutical development. By
bridging the gap between heterogeneous reagents/catalysts and common automated reaction platforms, this
research has strong potential to expand the impact of high-throughput experimentation in organic chemistry
thereby accelerating the synthesis and identification of molecules important to human health.

Public health relevance
Public Health Relevance This proposal aims develop new materials and macromolecules that are compatible with modern approaches in organic synthesis. By addressing limitations of current systems, this work stands to (i) expand the scope of accessible molecules for potential application in pharmaceuticals and (ii) accelerate the identification of important molecules and (iii) lower the cost of pharmaceutical drugs to the public.